Behavioral and Social Sciences in Clinical Setting: Team-Based Patient Care

DESCRIPTION (provided by applicant): Enacting the Behavioral and Social Sciences in the Clinical Setting: Institution-Wide Teaching of Effective Team-Based Care The College of Physicians and Surgeons of Columbia University and the Weill- Cornell Medical Colleges propose to partner in a project to enhance what medical students learn about social sciences and behavioral sciences in their clinical training. The project will accomplish these aims in three broad ways: 1. Increase the amount of teaching offered to students in such topics as doctor- patient relationships, ethics and professionalism, understanding patients' lived experiences, and reflecting on their own practice. The schools plan to adopt innovative narrative methods to help medical students examine their own and their patients' experiences through reading, writing, and hearing the stories of others. These teaching efforts will take place in the hospital where students are themselves providing medical care to individual patients. 2. Increase the teaching skill of physicians and other medical school faculty in an intensive Faculty Scholarship Core. Committed teachers of social, cultural, interpersonal, and ethical dimensions of health care will be invited to work closely with their peers in developing effective teaching methods, creating new teaching approaches, pursuing their own scholarship and research in how medical students learn this material and how best it can be taught. They will be trained in scholarly and research methods so that they have the capacity to disseminate what they learn in academic presentations and publications, thereby improving the teaching of these materials widely. 3. Since the setting of care and the partners of care determine the nature of care, this project will pay great attention to the institutional culture of the teaching hospital in which the students train. Columbia and Cornell share the use of the NewYork-Presbyterian Hospital. The proposers of this project are already collaborating with nurses, social workers, public health professionals, and dentists who work in this hospital to improve team work and patient-centered care. The project would engage medical students in on-going team-based efforts throughout the hospital. Instead of being disillusioned by the indifference and greed of the real world of the hospital, this project will expose medical students to the idealism and commitment that most health professionals hold to patients' well-being. A rigorous evaluation plan is proposed, relying on in-depth interviews with faculty and students, careful systematic description of the hospital culture by students in narrative writing and questionnaires, focus group methods to learn what groups of health care professionals think about the care they give. The project anticipates that its work will improve the education of medical students, strengthen the scholarship and pedagogy of faculty, and enable the hospital to deepen its commitment to team- based, respectful, patient-centered care.

Public health relevance
Project Narrative This proposal describes the continuation/renewal of the K07 grant awarded to Columbia University to enhance social and behavioral science teaching in medical school curricula. Columbia has partnered with Weill-Cornell Medical College in this five- year project. The aims, briefly, are to enhance the clinical teaching to medical students in the teaching hospital environment of NewYork-Presbyterian, the hospital these two medical schools share. The methods include introducing innovative clinical teaching methods-to attending rounds, bedside rounds, for example-and also to amplify the small group teaching done for students on clinical clerkships and fourth-year electives. Both Cornell and Columbia are inaugurating Scholarly Projects within concentration tracks, and several of the concentration tracks available for students' study are in such social and behavioral science areas as global health, population and community health, and ethics and narrative practice. A Faculty Scholarship Core will be instituted to further faculty's ability to design and evaluate innovative pedagogic methods. This Core will be the "think-tank" for the educational enhancements, while also serving as a professional development training program for the faculty. Among many pedagogic research projects to be taken up is the effort to design and evaluate an assessment scale for the narrative writing that students are coached to do. Narrative analysis of students' writing may offer a powerful means to track developments over time and to learn fresh knowledge about how our hospital and schools work. Finally, the project partners directly with NewYork-Presbyterian Hospital to identify and modestly support efforts at team-based and patient-centered care. Instead of considering the institutional culture as a negative force disillusioning students with "real world" indifference or greed, this project believes that most health care professionals who work in our hospital are deeply committed to quality care and dignified care. The project will engage medical students directly with these efforts so as to expose the idealism of health care professionals to their view. At sites of team-based care, the project will initiate narrative medicine sessions in which interdisciplinary teams can gather to look seriously at the work they do, using reflective writing as a door into perception and understanding. The project will be evaluated with a rigorous and careful multi-pronged strategy relying on in-depth interviews, focus groups, student surveys, and students' narrative descriptions of the hospital and of the work they do. __SpecificAimsTextDelimiter__ Specific Aims: The R25 successor to Columbia's K07 project continues the effort to strengthen the teaching of social sciences and behavioral sciences in the medical school by emphasizing the roles of the teaching hospitals and the entire health care team in our teaching. The NewYork-Presbyterian Hospital, the major teaching hospital of the College of Physicians and Surgeons of Columbia University (P&S), will become our sphere of action. Since NewYork-Presbyterian is the main teaching site for two medical schools, Columbia's P&S and Weill Cornell Medical College, we expand our project to include Weill Cornell as our partner. Together, Columbia and Cornell can try to shape the clinical training our students derive in our shared hospital and to help our students to learn more effectively about the social and behavioral aspects of illness from their training in it. The first four specific aims outlined below cohere conceptually and, eventually, will in practice merge. The primacy of the power of stories in education and the influence of narrative actions on learning will continue to guide and unify our work. Conceptual frameworks from marrative medicine, reflective practice, and relationship-centered care will support our work toward all specific aims, and the narrative methods and metrics developed during K07 will be used in our work. 1. To develop a teaching and faculty-development partnership between the College of Physicians and Surgeons of Columbia University and the Weill Cornell Medical College as the two parent academic centers for the NewYork-Presbyterian Hospital. 2. To build the Faculty Scholarship Core at Columbia as the post-K07 stage of faculty development seminar to mature faculty members' research, scholarship, and publication in the teaching of social science and behavioral science to medical students and to enable them to achieve academic promotion on the basis of this work. 3. To enhance social sciences and behavioral sciences teaching to medical students in the hospital and ambulatory clinical settings at Columbia and Cornell, using and testing innovative methods from narrative medicine, reflective practice, and relationship- centered care. 4. Toward Specific Aim 2, to engage medical students in the institutional culture of NewYork-Presbyterian Hospital that emphasizes collaborative team-work and integrated patient-centered care and to participate in clinical and educational innovations that forward these aims, strengthening synergies with on-going institution-wide projects committed to these goals. 5. To expand the current behavioral and social science consortium from 9 to 18 schools, to continue our collaborations and national dissemination efforts, and to enhance our collective evaluation under the aegis of a coordinating center.